Vaccine Hesitancy: Exploring the Role of Temporal and Cross-country Variation in COVID Rules, Vaccine Media Coverage, and Public Health Policy Consistency

Project Summary
The project "Vaccine Hesitancy: Exploring the Role of Temporal and Cross-country Variation in
COVID Rules, Media Coverage, and Public Health Policies" will investigate the factors that
determine whether and how quickly individuals were willing to get the COVID-19 vaccination.
We leverage variation, over time, within and across sixteen countries, in COVID vaccination
policies, media coverage of the vaccines, and policy stances of public health authorities. We will
harmonize the COVID vaccination policies across all countries. In all sixteen countries, we link
national vaccination rate time series data to COVID vaccine policies and a harmonized set of
data on general COVID-mitigation policies that vary temporally. In fifteen of the sixteen
countries, we do so for vaccination rate time series data for sub national geographic units. In
fifteen of the sixteen countries, we will link the COVID vaccine and general COVID-mitigation
policies to individual level data. With these data, we will exploit the substantial temporal and
geographic policy variation, in and across countries, and individual demographic characteristics
to explain who did or did not get the vaccine and why.

Public health relevance
Project Narrative The project "Vaccine Hesitancy: Exploring the Role of Temporal and Cross-country Variation in COVID Rules, Media Coverage, and Public Health Policies" will investigate the factors that determine whether and how quickly individuals were willing to get the COVID-19 vaccination. We leverage variation, over time, within and across sixteen countries, in COVID vaccination policies, media coverage of the vaccines, and policy stances of public health authorities. We will link the policies to individual panel data and exploit the substantial temporal and geographic variation, in and across countries, to explain who did or did not get the vaccine.